Scientific Information Management and Literature-Based Evaluations for the DTT - Systematic Review of Flouride

The Division of Translational Toxicology (DTT) performs systematic reviews of literature to assess the potential for adverse effects on human health by agents, substances, mixtures, or exposure scenarios, based on information about human exposure. The findings of these reviews generally focused on either cancer or non-cancer effects and published as monographs. This review was conducted primarily by the DTT Integrative Health Assessment Branch on health effects of flouride.
Keywords: Systematic review, toxicology, epidemiology, exposure, non-cancer effects